SARS-CoV-2 immune responses in patients with lymphoma

Project Summary
Non-Hodgkin lymphoma and chronic lymphocytic leukemia (NHL/CLL) patients have immune system deficits
that arise from the cancer and are aggravated by lymphoma therapies, placing them at higher risk of morbidity
and mortality after infection with viruses like influenza and severe acute respiratory syndrome coronavirus 2
(SARS-CoV-2). Patients are strongly recommended to get vaccinated and boosted with SARS-CoV-2 mRNA
vaccines, but antibody responses after vaccination in these patients are often impaired. SARS-CoV-2 vaccines
also elicit T cell responses in healthy individuals that may be protective but previous studies indicate that T cells
from NHL/CLL patients are also dysfunctional.
Under the mentorship of Drs. Rafi Ahmed and Jonathon Cohen, I have assembled a cohort of over 600 NHL/CLL
patients with over 1,300 longitudinal blood samples paired with clinical data that I have used to study the immune
responses in this patient population. Using this cohort, I showed that most patients have lower antibody
responses after SARS-CoV-2 vaccination than otherwise healthy individuals and that antibody responses
correlate at least partly with lymphoma therapies. I have also shown that some patients produce spike-specific
CD4+ and CD8+ T cells after vaccination. The longitudinal, antigen-specific CD4+ and CD8+ T cell responses
after vaccination and infection have not been well characterized in NHL/CLL patients. I hypothesize that these
patients have alterations in their CD4+ and CD8+ T cell responses after antigen stimulation, which are dependent
on the underlying lymphoma subtype and lymphoma therapy.
This proposal has 3 goals: 1) To evaluate the generation, differentiation, breadth, and persistence of SARS-
CoV-2-specific CD4+ T cell responses in NHL/CLL patients after vaccination and infection using functional
assays and single cell sequencing technologies; 2) To define the primary and memory SARS-CoV-2-specific
CD8+ T cell responses after vaccination and infection through functional assays and single cell sequencing
technologies; and 3) to support my transition from a trainee in Dr. Ahmed’s laboratory to leading an independent
research program.
Successful completion of these studies will provide in-depth knowledge of the generation, evolution, breadth,
and persistence of antigen-specific T cell responses in NHL/CLL patients after vaccination and infection. This
knowledge will facilitate the design of interventions that may improve vaccine responses in these and other
immunosuppressed patients, protecting them from potentially life-threatening viral infections like SARS-CoV-2
and influenza. Moreover, the insights on the generation and maintenance of adaptive immune responses against
novel antigens obtained from these studies could help fuel the development of better cancer immunotherapies.

Public health relevance
Project Narrative Non-Hodgkin lymphoma and chronic lymphocytic leukemia patients have immune system deficits that prevent them from developing appropriate immune responses to vaccines, placing them at high risk of severe infections and death. This proposal focuses on defining the responses of a type of immune system cell, namely T cells, after COVID-19 vaccination and infection in these patients. This will allow us to look for ways to improve the efficacy of vaccines in these and other immunosuppressed patients.